Mechanisms of Iron-Containing Enzymes

Project Summary/Abstract
Enzymes that utilize iron-containing cofactors catalyze many different, often very difficult, chemical reactions that
are fundamentally important to central life processes, such as DNA biosynthesis and repair, gene regulation,
regulation of epigenetic inheritance, biosyntheses of numerous compounds with antibacterial and antifungal
activities. Dysfunction of these enzymes is often associated with the onset of severe diseases, e.g. cancer,
cardiovascular diseases, and diabetes. Strategies to harness the synthetic potential of these enzymes and to
treat diseases associated with their dysfunction involves the rational manipulation of these processes on a
molecular level, which requires a detailed knowledge of the reaction mechanisms, in particular how the enzymes
control the outcome of their reactions. The Bollinger/Krebs joint group specializes in combining transient-state
rapid kinetic experiments with various spectroscopic (e.g. stopped-flow absorption, freeze-quench EPR and
Mössbauer) and analytical (LC/MS) methods to monitor metalloenzyme reactions. In the last 20 years, our group
has successfully studied many mononuclear (MNHI) and dinuclear non-heme-iron (DNHI) enzymes by trapping
and characterizing key reaction intermediates in their catalytic cycles. We trapped and characterized high-spin
Fe(IV)-oxo (ferryl) intermediates in various MNHI enzymes. The ferryl intermediate initiates substrate oxidation,
typically by cleavage of an aliphatic C-H bond. The outcome of these reactions is diverse and includes
hydroxylation (the default outcome), halogenation, desaturation, epimerization, heterocyclization, and
endoperoxidation reactions. The current focus of our research aims at deciphering the factors that result in the
diverse outcomes. The long-term goal of this research is to lay the foundation for the rational manipulation of
these enzymes for biotechnological applications. In collaboration with the Boal group, the B/K group has
identified the heme-oxygenase diiron oxygenase (HDO) enzyme superfamily and currently studies several
HDOs. The PI also has a long-standing collaboration with the Booker group on mechanistic studies of radical S-
adenosylmethionine (RS) enzymes that catalyze formation of new C-S bonds. These enzymes use their [Fe4S4]RS
cluster to generate the canonical 5’-deoxy-adenos-5’-yl radical that initiates substrate oxidation by cleavage of
aliphatic C-H bonds and their auxiliary [Fe4S4] clusters as sulfur source. The current focus of the collaborative
research efforts on RS enzymes aim at delineating the reaction mechanisms of various RS enzymes involved in
formation of new C-S bonds.

Public health relevance
Project Narrative Iron-containing enzymes carry out a bewildering array of (often chemically difficult) transformations, of which many are of particular importance to human health, such as biosynthesis of many antibiotics, DNA biosynthesis, control and regulation of oxygen levels, and gene regulation. In our research we utilize a combination of experimental and theoretical methods to study the mechanisms of these reactions on a detailed, atomic level. Ultimately, we aim at rationally reprogramming iron-containing enzymes with the aim of harnessing and enhancing their potential for society.